EFFECTS OF ENDURANCE TRAINING ON MUSCLE PROTEIN SYNTHESIS IN WOMEN AND MEN

The specific aims of this proposal are to 1) determine the effects of endurance exercise on muscle protein (mitochondrial and myosin) synthesis in humans; and 2) determine whether the effects of endurance training are modulated by age.; 3) determine the effect of endurance training on body composition and cardiovascular disease.